Identifying and targeting neural subpopulations of the spinal cord that mediate chronic pain via cell-type-specific cis-regulatory elements

Project Summary/Abstract
Chronic pain is a common and debilitating medical condition, yet current treatment options are often ineffective
and have side effects. Recent experimental work has identified classes of neurons in the spinal cord that mediate
pain, which may be novel candidates for more targeted pharmaceutical intervention. However, there are two
issues limiting clinical translation. First, Genome Wide Association Studies in humans have given us genetic
markers of chronic pain, but we lack a genetic characterization of which cell types are affected by this genetic
variation. Second, we need a method of targeting these specific cell types in mice, non-human-primates, and
humans, the typical progression of testing for new therapeutics. I will make significant progress on both problems
by analyzing the genomic cis-regulatory elements (CREs) of neural subtypes in the macaque and mouse spinal
cord. Recent evidence suggests risk variants for many polygenic diseases especially accumulate in CREs. I
hypothesize that neuron subtypes identified as pain-mediating in anatomical studies will be genetically enriched
for chronic pain markers in CREs, compared to several controls. I further hypothesize that CREs evolutionarily
conserved across macaque and mouse are even more enriched relative to those not conserved, based on the
idea that CREs that are particularly important to function will be conserved.
To address the goal of in vivo targeting of these cell types, I will leverage the fact that CREs are highly cell-type-
specific drivers of gene expression, and can control the expression of an exogenous gene that could in principle
alter neuronal excitability for therapeutic benefit. I will develop a machine learning pipeline that identifies CREs
predicted to have high specific activity in target cell types. I will train models on mixed mouse and macaque CRE
data, and I hypothesize that cross-species models will identify more translatable CREs. This strategy may not
be optimal for pain treatment given the diversity of cell types involved in pain signaling, and my strategy may
require simultaneous control of complex combinations of neuron subtypes, while minimizing off-target effects
such as in motoneurons. I will therefore also design synthetic regulatory elements to preferentially target
combinations of pain-mediating neurons, with minimal effects in ventral horn neurons such as motoneurons. I
will take the top CRE candidates from my machine learning models and validate their cell-type-specificity activity
in mouse with RNAScope experiments, and collaborators will validate CREs in macaque in a related project.
In summary, I will characterize the genetic risk burden of chronic pain in evolutionarily conserved neuron
populations, which will inform us of genetic pain mechanisms across experimental animal models. I will
computationally identify and design CREs that target these populations, and validate their function in vivo in
mouse, providing a valuable tool for pain experiments, and making progress toward a new form of pain therapy.

Public health relevance
Project Narrative In an effort to develop new tools to study pain in the spinal cord, as well as a new chronic pain treatment, I will first use statistical genetics to identify families of neurons in the spinal cord that have a genetic risk of malfunctioning and causing chronic pain. As a strategy to selectively activate or shut off these neuron families, I will then use machine learning to find, and design, DNA sequences, called cis-regulatory elements, which are predicted by my models to drive gene expression in just these neuron families, in order to block pain signaling without causing off-target effects. Finally, I will experimentally validate that these cis-regulatory elements indeed have specific activity in mouse, and collaborators will do the same in macaque; cis-regulatory elements discovered or designed in this project will serve as a useful resource for functional pain experiments in animals, and potentially for a novel therapeutic.